Neural circuits that mediate computation of salience

PROJECT SUMMARY / ABSTRACT
A fundamental function of the nervous system is to determine salience of sensory stimuli in the environment
and accordingly regulate attentional response to them. Salience is dynamic. What is salient to an animal
changes from moment to moment in accord with its experience and current physiological need. A prime
example observed widely across species is the salience of food-associated stimuli. These stimuli are salient for
food-deprived animals and therefore demand their attention. By contrast, food-associated stimuli lose their
salience when animals become satiated. This indicates that neural circuits that control attentional behavior
integrates the information of hunger and satiety. Appropriately determining salience based on current need and
thereby regulating attention is essential for survival and its dysregulation is associated with neuropsychiatric
disorders. However, it is not known what neural circuits mediate attentional behavior and how these circuits
integrate internal information of hunger and satiety. Here we propose to use Drosophila as a model to dissect
neural circuits that control attentional behavior to food-associated olfactory stimuli in accord with hunger and
satiety. We employ a multidisciplinary approach that combines a novel behavioral assay, a novel bidirectional
neural activity reporter, genetic and optogenetic manipulations, and in vivo recording of neural activity to test
our hypothesis that a dopamine-modulated olfactory center, the mushroom body, plays a key role in
appropriately computing salience of food-associated odors based on current hunger state. In Aim 1, we will
establish that the salience of food odor is modulated by hunger state and will determine the role of mushroom
body in generating attentional response to olfactory stimuli. In Aim 2, we will identify hunger-sensitive
dopamine neurons, whose activity is modulated by signals reflecting hunger and satiety. In Aim 3, we will
identify mushroom body output that integrates information of food odors and hunger state to drive attentional
behavior. Together, our studies will reveal the neural mechanisms that regulate attentional behavior in
response to food-associated odors in accord with hunger state. The functional organization of the Drosophila
mushroom body exhibits remarkable similarity to that of the mammalian striatum and its dopamine input, and
the dopamine circuits in mammals have long been implicated in computation of salience. Therefore, we expect
that our project will contribute to providing an understanding of the operational principles of neural circuits that
mediate salience determination.

Public health relevance
PROJECT NARRATIVE Appropriately regulating attention in accord with current need is essential for survival, and dysregulation of this process is associated with numerous neuropsychiatric diseases, including substance use disorders and eating disorders. Our project will determine how dopaminergic circuits integrate physiological need and regulate attentional behavior. Obtaining a mechanistic understanding of how attention is regulated by these circuits will provide a foundation for developing therapeutic interventions for attentional dysfunction.